Identification of Speg Binding Proteins and Phosphorylation Targets in Skeletal and Cardiac Muscle

Title: Identification of Speg Binding Proteins and Phosphorylation Targets in Skeletal and Cardiac
Muscle
Abstract
Severe life-threatening skeletal muscle and/or cardiac myopathies including centronuclear myopathy (CNM)
and dilated cardiomyopathy are caused by mutations and/or deficiency of Speg (striated muscle preferentially
expressed Ser/Thr protein kinase). Speg is at least partially located in triadic/dyadic junctional regions in
skeletal and cardiac muscle. The mechanisms of Speg activation and Speg’s functional roles, binding proteins,
and phosphorylation targets in skeletal and cardiac muscle remain to be fully elucidated. Current methods of
assessing protein interacting partners suffer from lack of reproducibility and high levels of nonspecific
interactions. This is particularly true for Speg. We created mice with a V5/HA tag inserted into Speg to use for
anti-HA-Speg immunoprecipitations to identify Speg binding proteins. In this application, we will elucidate Speg
interactome and identify Speg phosphorylation targets in the skeletal and cardiac muscle using optimized
state-of-the-art mass-spec-associated proteomics techniques with parallel reaction monitoring (PRM). We will
also identify phosphorylation sites on RyRs, Jph2 and Speg that are reduced by Speg deficiency. Our specific
aims are to: SA 1: Define the effects of Speg deficiency on the muscle proteome. SA2: Identify Speg binding
partners using mice with V5/HA tagged Speg. SA 3. Identify and quantify phosphorylation sites on RyRs, Jph2
and Speg and assess the effects of Speg deficiency on these sites. Successful completion of this study will
identify Speg binding proteins and identify phosphorylation sites on its major targets. While this application
centers on interactions and targets of Speg, the techniques developed will be applicable to other skeletal and
cardiac muscle proteins.

Public health relevance
Project Narrative (3 sentences) Determination of Speg (striated muscle specific Ser/Thr kinase) binding proteins and extent/sites of target phosphorylation is crucial to develop therapeutic interventions for severe skeletal muscle and cardiac diseases associated with Speg mutations. To do that, we will use unbiased state-of-the-art mass-spec proteomics.